Emotional and biobehavioral mechanisms of parent-infant emotional synchrony

Project Summary/Abstract
My career goal is to lead a transdisciplinary research team that investigates multi-level mechanisms leading to
optimal child socioemotional development from the perspective of early-life dyadic emotional synchrony. The
overarching goal will be to implement translational, mechanistic and clinical research to uncover the emotional
and biobehavioral origins of parent-infant emotional synchrony and the pathways through which early dyadic
interactions lead to socioemotional functioning across the life course. Ultimately this work will lead to the
development of appropriately targeted interventions to promote early relational health and optimal child
socioemotional functioning. To effectively establish and lead this research program, I require additional training
in mother-infant ECG/EEG, qualitative interviews of subjective experiences, multimodal data integration
(qualitative-quantitative, neuro-bio-behavior, longitudinal), biostatistics, psychology and neuroscience. My
training to date has provided me with a strong foundation of skills in intervention research, experimental designs
and early relational health from the lens of parental sensitivity. My career development plan expands on this skill
set to provide essential further training in human dyadic face-to-face interactions, electroencephalography
(EEG), electrocardiogram (ECG), analyses of biobehavioral synchrony, qualitative methods and biostatistics. By
engaging in this protected training time, I will enter my independent stage of research well prepared to lead a
research team purposefully established to study the origins of social cognition from the lens of parent-infant
dyadic emotional synchrony. Studies have found that parent-infant dyads synchronize their heart rhythms and
brain activity during episodes of face-to-face matched behaviors (behavioral synchrony). Biobehavioral
synchrony, i.e., coordination of brain, heart and behavioral signals between parents and infants when engaging
in face-to-face interaction, provides a basis for studying parent-infant dyadic interactions in the first 12 months
as a mechanism leading to improved socio-emotional functioning in later years. The mechanisms underlying
biobehavioral synchrony are still relatively unknown. Here, we hypothesize that emotional synchrony may be a
vehicle strengthening biobehavioral synchrony. The K99 study aims to identify the biobehavioral (Aim 1) and
emotional (Aim 2) correlates of mother-infant emotional synchrony. The R00 study (Aim 3) will expand the K99
aims to mother-infant and father-infant dyads, and link emotional and biobehavioral synchrony to later child
socioemotional functioning.

Public health relevance
PROJECT NARRATIVE This K99/R00 Pathway to Independence Award seeks to provide training in parent-infant ECG/EEG, qualitative interviews of subjective experiences, multi-modal data integration (qualitative-quantitative, neuro-bio-behavior, longitudinal), advanced biostatistics, psychology and neuroscience to support the applicant’s transition to research independence. Through the training plan, the applicant will develop the skills and expertise necessary to establish a trans-disciplinary translational research program that integrates multiple novel subjective and biobehavioral measures into the study of human dyadic interactions, to uncover mechanisms of parent-child dyadic relational health – with a primary focus on emotional synchrony – that yield long-term health and wellbeing through optimized socioemotional functioning. This approach may lead to the development of precision interventions that improve socioemotional functioning based on deeply characterized emotional and biobehavioral processes.